Investigating Disparities in Home Health Access and Quality for Medicare Beneficiaries with Alzheimer's Disease and Related Dementias Following Recent Payment System Revisions

PROJECT SUMMARY
Of 5.4 million persons with Alzheimer's Disease and Related Dementias (ADRD) in the US, 70% live
in the community and are at high risk for unmet care needs. Medicare home health (HH) is a crucial source of
care for community-living older adults with ADRD, delivering skilled nursing, therapy, and aide services in the
patient's home. Patients can enter HH following an inpatient stay (post-acute HH) or referral by a community
physician (Community-Entry Home Health (CEHH)). Nearly half (44%) of Medicare HH episodes are CEHH.
Those with ADRD are especially likely to access CEHH. Prior research shows that 30% of CEHH patients have
ADRD, compared to just 12% of post-acute HH patients.
Recent changes to Medicare HH reimbursement under the Patient-Driven Groupings Model (PDGM)
adjust payment by referral source; PDGM is projected to reduce average reimbursement for CEHH by 11% while
increasing average reimbursement for post-acute HH by 29% (holding other patient characteristics constant)
and does not adjust for patient ADRD status. These changes have prompted concerns that PDGM will negatively
impact CEHH patients, especially those with ADRD. The only existing analysis of PDGM's effects on HH
utilization fails to examine differences by referral source (community vs post-acute), investigate impacts among
vulnerable beneficiary subpopulations, such as those with ADRD, or study changes in patient outcomes.
The goal of the proposed research is to assess PDGM's impact on CEHH access, care delivery, and
outcomes for community-living older adults with ADRD. We will link Medicare claims, HH assessment, and HH
agency data, along with geographic data from the American Community Survey, for a 100% sample of Medicare
beneficiaries from 2019-2021. Specific aims are: (1) Characterize PDGM's impact on CEHH access for
community-living Medicare beneficiaries with ADRD, (2) Determine PDGM's impact on CEHH care delivery (e.g.,
number and type of visits) for patients with ADRD, (3) Assess PDGM's association with CEHH outcomes (e.g.,
hospitalization, Emergency Department visits) for patients with ADRD. In all aims, we will adjust for social and
clinical characteristics of the older adult, as well as characteristics of their zip code and state of residence, and
the HH agency providing care. PDGM was implemented in 2020, but due to service disruptions related to COVID-
19, we consider 2019 as the “pre” period and 2021 as the “post” period (available evidence shows patient volume
and average comorbidity scores stabilized by 2021, reflecting 2019 levels).
This research is needed to assess whether a new payment system (PDGM) has contributed to disparities
in HH access and quality for those with ADRD. Findings will provide the first evidence regarding PDGM's impacts
on CEHH care for those with ADRD and could inform payment system revisions aimed at ensuring accessible,
high-quality home-based care for this high-need subpopulation. This work is especially timely given the upward
trend in HH utilization and growing numbers of community-living individuals with ADRD.

Public health relevance
PROJECT NARRATIVE A large and growing number of community-living older adults with Alzheimer's Disease and Related Dementias (ADRD) rely on community-entry home health (home health episodes not preceded by a hospitalization) to help meet their care needs. Recent changes to Medicare home health reimbursement under the Patient-Driven Groupings Model (PDGM) reduce payments for community-entry home health and do not adjust for patient ADRD status in risk adjustment models, potentially threatening access and quality for this high-need subpopulation. The proposed research will assess PDGM's impact on community-entry home health access, utilization, and outcomes for older adults with ADRD, yielding critical evidence to inform ongoing policymaking and future revisions to PDGM.